Identifying Regulators of Cellular Aging that can Prevent Alzheimer's Disease

ABSTRACT
Aging is the leading risk factor for Alzheimer’s Disease (AD) and many other chronic diseases, with more than
6.5 million cases of AD in the US. Regulating or slowing cellular aging, particularly in microglia and astrocytes
that regulate neuroimmunity, would have a major impact on the treatment of AD, but the proteins that control
cellular aging processes are poorly understood. Cellular aging has been characterized into 9 “hallmarks” or
phenotypes that define aged cells. Most hallmarks are a result of cellular stress, such as DNA damage and
oxidation, and are inter-related in both their causes and outcomes. The cellular aging process is linked to
dramatically altered gene expression, which is largely controlled by transcription factors (TFs). Longevity
studies between species also suggest that TF activity can define the rate of aging. We hypothesize that TFs
can modulate cellular aging and that identifying the TFs that play a role in aging processes will enable an
entirely new generation of therapeutic targets with the potential to treat, delay, and possibly even prevent AD.
The discovery of TFs that can improve the lifespan of patients would have a profound impact on the prevention
and treatment of AD and many other diseases.

Public health relevance
PROJECT NARRATIVE The human health significance of the proposed work is the identification of new targets for Alzheimer’s Disease (AD) and other diseases by identifying transcription factors (TFs) that can slow cellular aging. Currently, no drug on the market targets the underlying disease process of AD, and therapeutics against traditional targets in AD have repeatedly failed in late-stage clinical trials. The lack of AD treatments and the high co-morbidity of aging and chronic disease highlight an urgent need to identify new therapeutic targets. The mechanisms of aging uncovered in our studies ultimately will be translated into therapeutics as nutritional, pharmacological, or gene therapy interventions targeting either the TFs themselves or the gene products and pathways controlled by the TFs. The ability to rapidly reprogram and create engineered cells also has a large platform potential for identifying other drug targets, creating engineered cell therapeutics, and improving biologics manufacturing.